Retraction or reshaping: dissecting the role of mitochondrial ROS in synaptic plasticity

PROJECT SUMMARY
Neuronal function requires the reshaping and rewiring of neural connections through a
fundamental process named synaptic plasticity. It is well known that the strength of
neurotransmission is regulated by feedback signaling between the pre- and postsynaptic
neuron, which leads to short- and/or long-term structural adaptations. However, little is
known about how this regulation occurs. The current objective is to elucidate this missing
mechanistic link by exploring emerging signaling roles of mitochondria, which are
organelles that sustain the local energy demand of synaptic function and plasticity. Based
on the rationale that neuronal activity sets the pace of aerobic energy conversion and of
emission of chemically reactive oxygen species (ROS) from mitochondria, we hypothesize
that controlled and localized mitochondrial emission of ROS regulates synaptic function
and plasticity. Our preliminary data show that emission of mitochondrial ROS can be
elicited specifically in presynaptic terminals in vivo. We will pioneer in the use of
optogenetics for synchronized induction and measurement of ROS emission during
synaptic function. Functional ROS signaling targets will be explored using super resolution
fluorescence microscopy and mass spectrometry. Importantly, our collaborators and we
established a method to elicit and study synaptic plasticity within just a few hours using
optogenetics in vivo. Our results will impact therapies aimed improving neuronal
communication in age-related neurodegeneration.

Public health relevance
PROPOSAL NARRATIVE Our study will address how neurons constantly reshape their connections and adapt to ever changing levels of normal activity, as this process is known to be impaired after certain types of brain injury, and during age-related neurodegeneration. We will identify what neuronal factors are responsible for this reshaping process through the use of transgenic fruit flies in which we can specifically control and measure the strength of discrete neuronal connections. The results will have a direct impact in drug design and treatment interventions for age-related neurodegenerative diseases. ! !